The Role of Neurotensin-Expressing Neurons of the Extended Ventrolateral Preoptic Nucleus in REM Sleep Regulation

Project Summary/Abstract
Sleep is an active process requiring the participation of delimited nodes of sleep-promoting cell
populations. Work over the last twenty years has demonstrated that galanin expressing neurons in the
ventrolateral preoptic (VLPOGal) nucleus are necessary for normal sleep. While a portion of VLPO galanin
neurons is concentrated in a cluster, the so-called VLPO core (cVLPO), others are scattered dorsally and
medially to that core, a region that came to be known as the extended VLPO (eVLPO). Lesion and optogenetic
studies have demonstrated that the galanin expressing neurons in the cVLPO and those in the eVLPO are two
functionally distinct cell groups with the cVLPOGal neurons required for non-REM sleep (NREM) while the
eVLPOGal neurons required for REM sleep. Anatomical tracing studies have shown that the eVLPOGal neurons
innervate brainstem nuclei implicated in REM sleep regulation and through these descending projections, the
eVLPOGal neurons are thought to promote REM sleep by the disinhibition of the REM-generating neurons in
the pontine reticular formation. There remain however several fundamental gaps in our understanding of the
cellular and synaptic basis by which eVLPOGal neurons drive REM sleep. Studying the eVLPOGal population
has been proven to be quite challenging as the cVLPO and the eVLPO are small regions located in close
proximity and until now, there were no markers for selective targeting. We have recently discovered a potential
marker for the eVLPOGal neurons that will allow us to manipulate the eVLPOGal neurons independently from
their neighboring cVLPOGal neurons. Specifically, we have found that: 1) the eVLPOGal neurons selectively
express the neuropeptide neurotensin and, 2) that chemogenetic inhibition of the neurotensin eVLPO neurons
reduces REM sleep. We have also found that eVLPO neurotensin neurons send robust projections to regions
of the midbrain and pons that are known to suppress REM sleep including the ventrolateral periaqueductal
gray (vlPAG) and the locus coeruleus (LC). On the basis of these results, we propose that the eVLPO
neurotensin neurons promote REM sleep by disinhibiting REM-generating neurons in the pontine reticular
formation via inhibition of GABA neurons of the vlPAG and monoaminergic neurons of the LC. The current
proposal thus seeks to identify, first in vitro and then in vivo, the brainstem efferent outputs through which the
eVLPO neurotensin neurons drive REM sleep. To do so, we will first employ, in Specific Aims 1, in vitro circuit
mapping to identify the postsynaptic neurons that are targeted by the eVLPO neurotensin neurons. In Specific
Aim 2, we will use in vivo optogenetics to test whether the circuits first identified in the in vitro studies are
sufficient to produce REM sleep. Given the large knowledge gap this proposal seeks to fill, we expect results
from this work to provide 1) an important interpretative framework for future studies on the eVLPO neurotensin
pathways that are necessary and sufficient for promoting REM sleep and 2) more generally, a novel insight into
the role of the preoptic region in REM sleep regulation.

Public health relevance
Project Narrative The ventrolateral preoptic (VLPO) nucleus is a key brain area for the generation and the maintenance of sleep, and the extended VLPO region (eVLPO) contains neurons that are active during REM sleep and are REM sleep-promoting. The purpose of this project is to define the long-range circuit basis by which the eVLPO controls REM sleep. Successful completion of the proposed research will contribute to a better understanding of the role of the preoptic region within the circuits for REM sleep regulation.